Transgenerational consequences of pre-conceptional and in utero exposure to real-life chemical mixtures on fertility and metabolic health

Abstract
Global challenges to human health include a well-documented decline in human fertility and a dramatic increase
in the prevalence of obesity related metabolic disorders. There is now compelling evidence that these health
challenges are associated with environmental chemicals that can influence endocrine activity. However, this
premise has evolved from studies with acute single chemical exposures in altricial, genetically restricted, animal
models. The proposed study will address the central hypothesis that exposure to a real-life mixture of
environmental chemicals, prior to and throughout pregnancy, results in transgenerational epigenetic effects in
offspring that affect metabolism and reproduction. The proposal will use a unique, real-life chemical exposure
and a translationally relevant animal model whereby sheep are exposed to biosolids. Humans are exposed to a
wide mixture of environmental chemicals, at typically low concentrations, throughout their lifespan. Grazing
pregnant sheep on pastures treated with biosolids generated from human sewage provides a precocial model
with a developmental trajectory similar to humans. This provides a novel approach to examine the effects of
environmental chemical mixtures to which we are all exposed. The specific aims are: (1) to characterise lifetime
changes in metabolic function of male and female offspring spanning three generations (i.e. F1, F2 and F3)
following F0 exposure to biosolids treated pasture; (2) to assess changes in reproductive potential of male and
female offspring across three generations (i.e. F1, F2 and F3) following F0 exposure to biosolids pasture; (3) to
determine epigenetic changes, and their functional relationships, to transcriptional networks governing
transgenerational effects of maternal biosolids exposure on offspring metabolism and fertility. This
comprehensive analysis will provide proof-of-concept data on the effects of real-life chemical exposure in a
relevant experimental paradigm. This will significantly enhance our ability to predict and inform policy
development with the aim of ameliorating detrimental effects of environmental-chemical exposure and to improve
metabolic and reproductive health.

Public health relevance
Narrative We are all exposed to a plethora of environmental chemicals, which if they enter our bodies can have detrimental effects on function and health, but importantly can also potentially affect the health of our children and grandchildren. This project will capitalise on a unique animal model that has been established within the UK, brings together expertise from the Universities of Michigan, Glasgow (UK) and Nottingham (UK) to investigate the mechanisms by which a mother’s exposure to a real life cocktail of chemicals during pregnancy can affect the long-term metabolic and reproductive health of her offspring and that of subsequent generations.